Developmental programming of stress-sensitive neural circuits underlying social behavior

Project summary
Exposure to social stressors is an important risk factor for the development of mental illnesses such as
anxiety, depression, and post-traumatic stress disorder. Stress-related mental illnesses are more common in
women than men, and these differences arise during adolescence. Androgens work to change brain structure
and function during adolescence, how this transformation impacts behavior is poorly understood. We will test
the hypothesis that the activation of androgen receptors during puberty permanently programs neural circuits
of social behavior to be less sensitive to social stress. Our studies will be conducted using California mice
(Peromyscus californicus), an ideal model system for studying adolescent development. In this species
adolescence lasts almost twice as long as conventional mice and rats, which will allow us to apply advanced
neuroscience and molecular methods in way that would be difficult or impossible in standard model systems.
In adult California mice, females but not males exposed to social defeat stress orient towards an unfamiliar
target mouse while simultaneously avoiding it, a behavior we define as social vigilance. However, in juvenile
California mice, social stress increases social vigilance in both males and females. In males, prepubertal
castration results in female-typical social vigilance responses in adulthood, while pubertal treatment with the
non-aromatizable androgen dihydrotestosterone reduces sensitivity to social stress in both males and females.
We will test the hypothesis that activation of the androgen receptor (AR) during puberty permanently
programs neural circuits of social behavior to be less sensitive to social stress.
First, we will use CRISPR-based gene editing to knock-down AR expression in ventral hippocampus
(vHPC) neurons projecting to the bed nucleus of the stria terminalis (BNST) or nucleus accumbens (NAc). The
prolonged development of this species will allow us to knock-down AR expression before the onset of
adolescent development. Second, we will use state-of-the-art sequencing methods to identify AR genomic
binding sites in the vHPC and assess maturation of hippocampal cells with single-cell resolution. Finally, we
will determine how circuit-specific AR knock-down alters membrane excitability of vHPC neurons using whole-
cell slice electrophysiology. These analyses bridge the gap between the molecular and behavioral data in the
other aims. Our team is ideally suited to execute these studies. Dr. Trainor is a leader in developing the
California mouse stress model and open access tools. Dr. Tollkuhn is a leader in the application of modern
sequencing methods to identify the molecular mechanisms of sexual differentiation of the brain. Dr. Robison is
a leading expert in the use of electrophysiological approaches to study the impact of stress on neural circuits.
The proposed studies will be the first to identify androgen-dependent molecular pathways activated during
adolescent development in neural circuits that drive translationally relevant behavioral responses to stress.

Public health relevance
Project Narrative Social anxiety is more common in women than in men, but the underlying mechanisms are unknown. The proposed experiments use rodent models to determine the mechanisms through which gonadal hormones shape neural circuits that mediate social approach and vigilance during adolescence.